Mechanisms of Obesity-related Altered Stomach Plasticity

Project Summary
Individuals with type 2 diabetes and obesity are at greater risk for developing gastrointestinal diseases including
Crohn’s disease, gastro-esophageal reflux disease, various gastrointestinal cancers, as well as diverticulosis. In
order to develop treatments to reverse pathogenesis, it is necessary to determine how cellular changes to the
tissues of the gastrointestinal tract contribute to disease. Interestingly, the expression of genes in the stomach
are more strongly altered compared to regions of the small and large intestine during obesity. And while the
abundance of many gastric cells, particularly hormone-secreting endocrine cells, are increased with disease,
there is evidence to support that these cells are dysfunctional. The mechanisms initiating these changes remain
unclear. Endocrine cells are repopulated from stem and progenitor cells. In preliminary evidence presented in
this proposal, the candidate has found that there are more gastric Neurog3+ endocrine progenitor cells, but
minimal change in Lgr5+ stem cells, with disease, the latter of which is different from what is found in the intestine.
Furthermore, the candidate has found a cell-specific increase in Notch components in the stomach of mice after
high fat diet feeding. Using two specific aims, the goal of this proposal is to determine how obesity alters
the function and distribution of gastric endocrine progenitor cells. The hypothesis is that lipotoxicity
disrupts stem and progenitor cell homeostasis through altered Notch signaling. In Aim1, through gain-of-
function studies in mice, the candidate will directly test whether activation of Notch signaling contributes to the
metabolic dysregulation and altered function of gastric endocrine cells that occurs during obesity. In Aim2, using
fluorescent reporter mice to mark progenitor and lineage-committed endocrine populations, the candidate will
perform single cell RNA-Seq to isolate unique populations of dysfunctional gastric endocrine cells. In addition,
using a targeted approach, the candidate will also directly test, using knockout mice, the role of the Notch ligand
Jag1 in promoting the expansion of endocrine cells with obesity. Upon completion, the applicant will have created
a detailed picture on how unique populations of gastric endocrine cells are altered by obesity. The applicant will
also elucidate how specific signaling mechanisms, such as altered Notch signaling, are connected to disease
pathogenesis. Together, these studies will form the basis of an R01 grant, are necessary to permit a more
complete analysis of regional specific differences in endocrine cell lineage, and will shed light on new
therapeutics for diabetes and obesity.

Public health relevance
Project Narrative Many people with diabetes and obesity suffer from gastrointestinal complications. Herein, the candidate has discovered that diabetes and obesity drastically alters stomach tissue. This grant will determine specifically how stomach cells are altered with disease and uncover the mechanisms driving these changes.